Resonance enhanced CMOS sensors for high-throughput sensing

PROJECT SUMMARY/ABSTRACT
Microsystems for the detection of biomolecules can play important roles in biomedical research, clinical
diagnosis, food safety, homeland security and pharmaceutical testing. The research objective of this
proposal is to develop an ultrasensitive and high-throughput complementary metal–oxide–
semiconductor (CMOS) sensors including over 10,000 sensor units on a 1-inch chip that could
provided high-resolution spectroscopic information with combined features of label-free, high
sensitivity, high throughput, small size, and easy integration with existing electronics. Each sensor unit
is composed for surface-functionalized silica-based high-quality whispering-gallery-mode (WGM) resonators
that approximate the size of eukaryotic cells for ultra-sensitive label-free biosensing of specific proteins,
biomarkers and protein-protein interactions. The basis for the technology is the physical associations and
interactions of biomolecules on a microresonator surface alter the residence time of photons in a way that can
be measured and quantified by a novel photonic crystal (PC) integrated CMOS spectrometer. Moreover, the
proposed PC-CMOS is expected to achieve a video-frame rate of spectroscopy with a large field of view (FOV)
(2 cm × 2 cm) and high spectral resolution (1 pm). The unique features of the proposed sensor lie in two
advantages: (1) ultrasensitivity enabled by significantly enhanced light-matter interactions in high-quality WGM
optical microresonators; and (2) high-throughput sensing mechanisms adopted from CMOS originally
developed in the semiconductor industry for communications and electronic products. Our objective will be
achieved by completing the following three specific aims. Aim 1 will develop PC slab spectrometer on a CMOS
chip for wide-field high-resolution spectroscopy. Aim 2 will design, fabricate, measure, and optimize the
surface-grating-waveguide-coupled WGM microsensor arrays. Aim 3 will demonstrate resonance-enhanced
high-resolution CMOS spectrometer. The proposed research contains three main innovations: (1) the
novel WGM sensor arrays are expected to offer several orders of magnitude higher sensitivity than existing
sensing technologies, such as ELISA; (2) PC slab spectrometer on a CMOS chip, which enables a single-shot
detection of over 10,000 optical mode spectra of the WGM microsensors and resonance-enhanced Raman
spectroscopy; (3) integrating ultrasensitive WGM sensors with CMOS technologies to realize a new system
leading to a disruptive technology for sensing applications where high sensitivity and high throughput are
desired. This project is significant because successful completion of this work will lay the foundation for the
development of a new biosensor with great potential to advance clinical diagnosis and biomedical research by
revolutionizing conventional sensing technologies by leveraging the existing technologies in semiconductor
industries. If successful, the technology developed in this project will be able to serve as a powerful tool for NIH
R01 projects targeting for an in-depth understanding of specific diseases or medical problems.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant for public health because it will develop a novel high-throughput biosensor that could be of great use for early disease diagnosis, pharmaceutical testing, and medical research. This novel sensor potentially has the combined features of label-free, high sensitivity, high throughput, small size, and easy integration with existing electronics. The resonance-enhanced CMOS sensor system with spectroscopic information has the potential to revolutionize and replace conventional enzyme-linked immunosorbent assays (ELISA).